Metabolic and epigenetic reprogramming in cyclin E high ovarian cancer

Project Summary/Abstract
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as “NOT-CA-
24-044”.The ultimate goal of this proposal is to address a fundamental gap in knowledge on the role of CCNE1
driving metabolism in uterine serous carcinoma (USC). The results from these studies could have a significant
impact on the mechanistic understanding of the ~20-30% of USC tumors with CCNE1 amplification. This re-
search plan focuses on assessing the homologous recombination (HR) proficiency of CCNE1hi USC and the
contribution of nucleocytoplasmic acetyl-CoA metabolism and its associated histone acetylation to this pheno-
type. Moreover, they will provide a more global understanding of metabolic reprogramming in CCNE1hi USC and
identify novel therapeutic strategies to synergize with standard-of-care DNA damaging chemotherapies. The
completion of the scientific aims of this proposal will not only provide new mechanistic insights into the interplay
between the acetyl-CoA-mediated metabolic-epigenetic axis in USC, but will also establish targeting metabolism
in this highly aggressive disease. The proposed research is of high impact because little is known about molec-
ular mechanisms driving CCNEhi USC. Moreover, these studies have the potential to impact the management of
CCNEhi USC.

Public health relevance
Project Narrative CCNE1 is amplified in 20-30% of uterine serous carcinoma (USC), but little is understood about how CCNE1 drives the aggressiveness of this disease. In this study, we will assess the DNA repair proficiency of these tumors in addition to exploring new metabolic therapeutic strategies to sensitize these tumors to standard-of-care chem- otherapy. The results will have a direct impact on the development of novel strategies to obtain a therapeutic response in CCNE1hi USC.